Leadership, Planning and Evaluation

PROJECT SUMMARY/ABSTRACT - LEADERSHIP, PLANNING AND EVALUATION (LPE)
The Leadership, Planning and Evaluation component of the Cancer Center Support Grant (CCSG) develops and
implements a vision for the University of Chicago Medicine Comprehensive Cancer Center (UCCCC), and
addresses Center’s overall goals, policies and operations. It serves as the framework for obtaining effective
internal and external advice, setting priorities, making decisions and defining, evaluating and executing the
Strategic Plan. Significant and substantial changes took place in Senior Leadership over the past funding period.
Kunle Odunsi, MD, PhD, a well-regarded physician/scientist with immense Cancer Center experience, was
recruited as Director of UCCCC in March 2021. Odunsi identified a new Deputy Director and 6 new Associate
Directors (ADs), 2 of which are new AD positions: AD for Diversity, Equity and Inclusion and AD for Shared
Resources. Senior Leadership sets the goals with guidance from the Executive Committee, program leaders,
component leaders, community members, as well as internal and external advisory committees. During the
current funding period, the Senior Leadership Team led a comprehensive strategic planning and evaluation
effort. This resulted in a five-year Strategic Plan (2022-2027), that robustly aligns programmatic initiatives and
organizational priorities for the Cancer Center. A formal External Advisory Committee (EAC) meets annualy,
along with mini-EAC Retreats throughout the year addressing specific components of the CCSG, to provide
objective evaluation and advice to the Director. The external advisors are appropriately balanced for basic
laboratory, clinical, prevention, cancer control and population science and administrative expertise. UCCCC led
seminars, retreats and workshops aim to stimulate transdisciplinary research opportunities and assessment of
implementation of strategic goals. The aims of Leadership, Planning and Evaluation are: (1) To establish a
leadership structure to support the UCCCC mission; (2) To engage in planning and development of a unified
Strategic Plan and develop tactics to execute strategic decisions and oversee implementation of the Strategic
Plan; (3) To track success, implement change, and evaluate performance of the UCCCC using external and
internal advisory groups. Overall, Odunsi and the UCCCC Senior Leadership team have effectively utilized the
Cancer Center Support Grant to put in place a vigorous and robust process of vision setting, evaluation of
progress, implementation of improvements, and planning for the future.